NOURISH: Nutrition and Outcomes of Reproductive Injury and Stillbirth related Harms

PROJECT SUMMARY
Placental dysfunction causes more than half of preventable stillbirths in the United States. Placental
dysfunction also causes preeclampsia, fetal growth restriction, and gestational diabetes, which can represent
near misses for stillbirth. Stillbirths can be prevented by identifying pregnancies at increased risk and using
increased fetal monitoring and sometimes early delivery before stillbirth occurs. Current ways of assessing
pregnancy risk misses the majority of people who go on to have a stillbirth. Existing biomarkers of
placental health fail to detect most placental dysfunction occurring later in pregnancy. Focus on nutritional
health and allostatic load could improve pregnancy risk assessment, as they are both associated with
cardiometabolic risk factors for placental dysfunction. Allostatic load is the inflammatory state caused by
chronic exposures to stress, such as racism. Assessing allostatic load and maternal nutrition helps address
inequities in stillbirth. Dietary intake represents a potentially modifiable risk factor and thus a target for
intervention to improve pregnancy health. To reduce the incidence of stillbirth, we must improve 1) our
understanding of how allostatic load contributes to placental dysfunction, and 2) the role of nutrition in placental
dysfunction. Without this knowledge, we are limited in assessing pregnancy risk and identifying impactful
interventions to prevent stillbirth. Our long-term goal is to improve prediction and prevention of stillbirth. We
propose rigorous evaluation of the impact of allostatic load and perinatal nutrition on placental dysfunction. The
main objective of this project is to identify the effect of allostatic load and dietary patterns on pregnancy
outcomes and placental health. The secondary objective is to advance the field of placental biology using novel
assessments of placental function in order to improve detection of placental dysfunction during pregnancy. Aim
1: Measure incremental benefit of adding allostatic load biomarkers to classic placental biomarkers in
predicting risk of clinical placental dysfunction. Aim 2: Determine the association between perinatal nutrition
(ultra-processed food consumption and Healthy Eating Index) and clinical placental dysfunction. Aim 3:
Determine association between key biomarkers of placental health and allostatic load and novel measures of
placental tissue function and stress. To test these aims, we will enroll 495 pregnant participants prior to 14
weeks' gestation and following them prospectively through pregnancy. We will conduct dietary assessments
and serial blood draws to assess allostatic load, cardiometabolic, and placental biomarkers at three time
points; two prenatal ultrasound assessments of fetal and placental development; and placental histology,
exosome, and trophoblastic functional evaluations to determine the role of allostatic load and nutritional
contributors in placental dysfunction. This work has the potential to reduce preventable stillbirth through
better risk assessment and improved placental health.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because the findings will provide important information about how to identify people at increased risk of stillbirth, which is key to stillbirth prevention. We also will identify both key nutrition factors that increase the risk of placental dysfunction and obstacles to optimal nutrition, a key equity challenge. The proposed project is relevant to one of NIH's strategic goals to “accelerate nutrition research” and the mission of the NICHD as it highlights detection and prevention of preventable stillbirth, novel measures of placental dysfunction, and a focus on inequities in stillbirth and pregnancy morbidity.